Mechanism of thrombosis in two myeloproliferative neoplasms (MPNs), polycythemia vera and essential thrombocythemia

Project Summary/Abstract
Arterial and venous thromboses are the major causes of morbidity and mortality in in two
myeloproliferative neoplasms (MPNs): polycythemia vera (PV) and essential thrombocythemia (ET),
associated with JAK2, and in ET in addition to JAK2 also calreticulin (CALR), and infrequently
thrombopoietin receptor (cMPL) somatic mutations. However, the molecular mechanism of
thrombosis is largely unknown. In multivariate analyses, the leukocyte count independently correlates
with their risk of thromboses. Our published work demonstrates that the hypoxia inducible
transcription factors (HIF-1 and HIF-2), which are upregulated in both granulocytes and platelets in
PV and ET, promote the transcription of prothrombotic and proinflammatory genes. Leukocytes are
the only source of tissue factor (TF) in the blood, and we also showed that PV neutrophils constitutively
express TF activity. Transcripts of Krüppel-like Factor 2 (KLF2) - a zinc finger transcription factor, are
down regulated in granulocytes and platelets from PV and ET patients and correlate inversely with the
transcripts of prothrombotic genes, suggesting that KLF2 might be a suppressor of thrombotic gene
expression in these conditions. In Chuvash erythrocytosis/polycythemia (CE) - a congenital disorder
associated with increased HIF-1 and HIF-2 due to a hypomorphic R200W mutation of the Von Hippel-
Lindau (VHL) gene, the incidence of thrombosis is higher than in PV and phlebotomy did not prevent
thrombosis but instead appeared to have facilitated it. Repeated phlebotomies induced iron deficiency
(ID) which further increased the level of HIF-1 and HIF-2 by inhibiting the negative HIFs regulator
prolyl hydroxylase domain 2 (PHD2) enzyme, which requires iron as a co-factor. Therefore, we
hypothesize that the up-regulation of HIF signaling in ET and PV granulocytes and platelets, perhaps
with an additional contribution of augmented inflammation, plays a central role in the development of
thrombosis. In order to achieve our objective, we propose to follow these specific aims (SA):
SA 1a. Determine whether the correction of ID decreases HIF signaling and ameliorates the thrombotic
milieu in PV and ET.
SA 1b. Determine the effect of HIFs in PV and ET thrombosis using inhibitors of HIF-1, HIF2 and JAKs.
SA 2. Extend our observations from mRNA transcripts of HIF-regulated, prothrombotic and
antithrombotic genes and inflammatory genes to the activity of TF in all blood lineages.
SA 3. Determine the role of KLF2 in increasing the risk of thrombosis in PV and ET and its regulation
and elucidate in more detail the interaction of KLF2 and HIFs.
We submit that proving our hypothesis will uncover novel mechanisms of thrombosis in PV and ET
and open new therapeutic targets for prevention of thrombosis in PV and ET.

Public health relevance
Project Narrative Polycythemia vera (PV) and essential thrombocythemia (ET) are forms of chronic leukemia caused by mutations in bone marrow cells (stem cells) that generate all types of blood cells including red cells, white cells and platelets. Patients with PV have too many red blood cells and patients with ET have too many blood platelets. Unlike the cells of other types of cancer, the blood cells in PV and ET look normal. What makes people with PV and ET sick, causing hospitalization and even premature death, are blood clots (thromboses). In this proposed research, we want to understand why patents with PV and ET have more blood clots. We intend to extend our recently published work and define the molecular mechanism of thromboses in more detail, hoping it will lead to a better understanding of the mechanism of thromboses in PV and ET and to new and better treatment.